Clinical study to evaluate the methylation signature of head and neck squamous cell carcinoma pain

ABSTRACT
The proposed research and career development plan have been designed to facilitate my path toward
becoming an independent surgeon scientist focused on highly translational head and neck squamous cell
carcinoma (HNSCC) research. I have devoted my early research career to exploring epigenetic mechanisms
(i.e., DNA methylation) of HNSCC pain, an area of research that has otherwise gone unnoticed. This proposal
builds on my previous research in which I determine that hypermethylation of pain-mediating genes contribute
to HNSCC pain in patients, and that hypomethylating agents treat HNSCC pain. The career development plan
is carefully structured to hone my expertise in clinical research through a series of courses, national meetings,
and meetings with my mentorship team. Upon completion of the K23, I will be well-prepared to apply for
independent research funding through an R01 mechanism, which will support my translational research program
focused on treatments for head and neck cancer pain.
In this proposal I take a systematic approach to identify genes that are methylated in patients with severe
HNSCC pain. In Aim 1 I prospectively enroll HNSCC patients, quantify their pain levels with validated pain
questionnaires, and collect their cancer tissue for analysis with a genome-wide methylation array. I will analyze
the methylation data and identify a suite of hypermethylated genes in patients with severe pain. I have proven
feasibility of this approach through preliminary studies, in which I used existing methylation data in HNSCC
patients to identify a list of hypermethylated genes. Many of these genes have not previously been associated
with pain processing. In Aim 2, I focus on one hypermethylated gene and determine whether adenovirus therapy
to re-express the gene produces antinociception in the preclinical model. The project is impactful because it
explores a pain mechanism that is largely unknown. The results will establish the methylation signature of
HNSCC pain. These genes could be targeted with either gene therapy or hypomethylating agents to treat
HNSCC pain, offering non-opioid alternatives and making the research clinically relevant, especially with the
current opioid crisis.
My mentorship and advisory team is comprised of individuals who have expert knowledge in all aspects of
translational and clinical research, specifically in the areas of cancer, pain, bioinformatics, and drug discovery,
all of which are critical for the proposed research. I receive protected time, laboratory space, start-up funding,
and personnel support. The career development plan and proposed research will bring me closer to realizing my
career goal of developing highly effective treatments for head and neck cancer pain.

Public health relevance
PROJECT NARRATIVE Head and neck cancer is one of the most painful malignancies, and is woefully unresponsive to even high doses of opioids. This study will 1) establish the relationship between pain experienced by head and neck cancer patients and specific genes that are silenced by methylation, 2) therapeutically target identified genes using a preclinical model, and 3) provide training to further the career development of the applicant as a surgeon scientist. The study has the potential to lead to a non-opioid treatment for head and neck cancer pain.